Determination of the genetic basis for B. burgdorferi mammalian infectivity

PROJECT SUMMARY
Lyme disease is the leading tick-borne bacterial disease in the world resulting an estimated 300,000 cases per year in the
US alone. Lyme disease is caused by tick-bite transmission of the pathogenic spirochete Borrelia burgdorferi (Bb). An
increased understanding of the molecular mechanisms that Bb uses to survive throughout its infectious cycle is critical for
the development of innovative diagnostic and therapeutic protocols to reduce the incidence of Lyme disease. Bb harbors a
reduced genome lacking many canonical metabolic, virulence and host defense evasion functions and a large number of
the genes in the Bb genome encode hypothetical proteins of unknown function uniquely conserved among Borrelia
species, together suggesting that Bb has evolved unique mechanisms to survive in the host that remain largely unknown.
In the previous funding cycle, we addressed one of the key challenges in the field of Bb molecular pathogenesis, definition
of the transcriptional activity of Bb during mammalian infection. Our novel synergistic approach combined development
and application of an in vivo expression technology (IVET)-method for Bb, genome-wide identification of the 5' end
transcriptome of Bb during growth in culture and infectivity analysis of targeted Bb mutants. This work contributed
significant insight into the Bb transcriptome in vitro and during infection and resulted in our discovery of a large number
of novel infection-expressed genes likely to contribute to Bb pathogenesis. These findings catalyze our current efforts to
address a critical unresolved gap in knowledge of the biology of this pathogen, which is elucidation of the molecular
mechanisms that allow Bb to overcome barriers to infection in order disseminate to distal tissues, leading to persistent
infection and therefore, the incapacitating symptoms of Lyme disease. The goal of this proposal is to elucidate the
molecular mechanisms that Bb uses to overcome host barriers to infection in order to disseminate. To achieve this goal we
have focused our studies on functional analysis of three novel genes, bb0318, bbk13 and bb0562, which our data indicate
play critical roles in Bb infectivity and dissemination due to their distinct contributions to Bb's ability to evade the early
immune responses of the host. We will elucidate the molecular mechanisms of bb0318-dependent resistance to oxidative
stress and immune-cell killing (Aim 1) and bbk13-dependent evasion of host complement (Aim 2) as well as define the
contribution of bb0562 to Bb infection (Aim 3). We propose a multidisciplinary approach for mechanistic analysis of each
of these novel genes, using cutting edge technologies in biochemistry, cell biology, microscopy and innate immunity as
well as in vivo live imaging, a diversity of mouse models and an experimental tick-mouse infectious cycle. The insight
gained from our work will significantly impact the understanding of the mechanisms of Bb dissemination, which in turn
will provide a foundation for novel approaches for Lyme disease interventions.

Public health relevance
PROJECT NARRATIVE Lyme disease is an emerging infectious disease caused by tick-bite transmission of the pathogenic bacteria Borrelia burgdorferi. It is not well understood how B. burgdorferi causes disseminated infection. This project investigates novel B. burgdorferi genes important for dissemination. These studies will contribute to an understanding of B. burgdorferi pathogenesis toward the development of improved treatments for Lyme disease.